Photoacoustic Imaging for Biophysical Physiological Indicators of Neonatal Intestinal Health and Necrotizing Enterocolitis

PROJECT SUMMARY
Necrotizing enterocolitis (NEC) is a devastating intestinal disease affecting the most fragile premature infants,
with mortality rates that persist at 20-40%. Accurate and conclusive early diagnosis of NEC remains elusive,
with limited diagnostic confidence complicating timely and effective medical management efforts to prevent
disease progression to urgent surgical removal of necrotic intestine. As the population of premature infants
at the highest risk for NEC continues to rise, a critical need has emerged to develop innovative clinically
translatable diagnostic methods to enable early interventional opportunities to combat this disease. Motivated
by the significance of the translational potential, clinical need, and extensive promising preliminary data, we
propose to investigate the development and use of photoacoustic imaging (PAI), an emerging non-invasive
imaging modality, in healthy neonatal intestine and NEC disease, representing a novel first-in-disease
preclinical investigation. PAI methods present enormous potential for fundamentally changing current clinical
paradigms by non-invasively detecting, diagnosing, and monitoring intestinal pathologies, such as NEC, in
premature infants. We hypothesize that PAI can accurately and quantitatively characterize changes in the NEC
vascular hallmark of intestinal tissue hypoxia and NEC intestinal functional hallmark of motility to improve the
diagnosis and monitoring of intestinal disease in premature infants. The aims of this application reflect a
stepwise development and validation study to optimize PAI acquisition and analysis methods to assess early
healthy development and NEC disease onset and progression in the neonatal intestine. In Aim 1, we will
optimize PAI measurements of neonatal intestinal tissue oxygenation. In Aim 2, we will optimize PAI
measurements of functional neonatal intestinal motility. Under each aim, we will compare quantitative
characterization of physiological biophysical indicators for neonatal intestinal microvasculature and function
from PAI with paired histopathological analysis. This enables our study to uncover the cellular and molecular
origins of observed changes on PAI. Combined, the proposed studies will establish PAI as a non-invasive
detection and quantitative imaging methodology to detect differences in neonatal intestinal tissue oxygenation
and functional motility in the healthy developing infant intestine and in NEC disease onset and progression.
The development of new advanced non-invasive imaging methods for neonatal intestinal disease presents
significant translational opportunity to improve the quality of care in the NICU. With considerable rationale and
strong preliminary data establishing feasibility for the use of PAI to detect changes in intestinal
microvasculature and function, this project has a high likelihood of demonstrating success in quantitative
characterization of NEC in these proposed first-in-disease studies. Our multi-disciplinary study team is well-
positioned to develop these innovative imaging methods specifically designed for feasible clinical translation as
a first-in-disease investigation to make a significant impact in intestinal health in premature infants.

Public health relevance
PROJECT NARRATIVE Necrotizing enterocolitis is a devastating intestinal disease affecting premature infants that presents significant clinical diagnostic difficulties due to the challenging disease and clinical setting. Advanced diagnostic imaging modalities are not routinely available for use in the fragile NICU patient population at risk for NEC and diagnostic confidence limits timely NEC diagnosis and effective medical management. This application investigates the development of new advanced non-invasive imaging and analysis methods to characterize biophysical physiological indicators of neonatal intestinal health and disease that presents significant translational opportunity to improve the quality of care in the NICU.